Mapping Immune Contexture and Crosstalk with Tumor Cells At GBM Margin

SUMMARY
Glioblastoma (GBM) remains deadly. A major reason is a highly infiltrative GBM border, making complete
surgical resection unattainable. Residual tumor cells inevitably spawn recurrent GBM, typically within 2-3 cm of
resection cavity. Understanding GBM margins is thus critical to curb GBM invasion and relapse. Tumor-
associated myeloid cells (TAMs) are the most abundant stromal cells in GBM, and they promote GBM expansion
and infiltration through immunosuppressive properties, secretion of tumor-promoting factors (gliomagens), and
preparation of invasion tracks. Previous research has largely focused on bone-marrow derived macrophages
(MDMs), which reside mostly in GBM interior, less is defined for microglia (MG), resident innate immune cells in
the brain that preferentially congregate at GBM margins. The current proposal intends to fill this gap by testing
the central hypothesis that perturbing the supportive niche provided by margin-MG may help slow down GBM
invasion and relapse. The premise of the approach rests on our compelling preliminary data establishing MG as
one of the most abundant immune cell populations at GBM borders. Furthermore, our pilot study demonstrated
that targeting MG proliferation (via IL-1/IL1R1 signaling) or MG motility/alignment (via axon guidance receptor
Plexin-B2) resulted in significant reduction of GBM growth and invasion. However, major knowledge gaps remain:
i) what are the signaling networks driving the persistence of tumor-promoting phenotypes of margin-MG, ii) does
genetic make-up of the tumor play a role in dictating the immune landscape at GBM margin, iii) what is the nature
of MG-derived gliomagens, iv) can we find a way to target margin-MG interactions with GBM cells, and v) how
does chemoradiation therapy alter gene signatures and tumor-promoting gliomagens of margin-MG? To address
these questions, in Aim 1, we will map the immune contexture and crosstalk with tumor cells at GBM margins
using multiplex immunostaining, advanced spectral flow cytometry, single cell transcriptomics, and spatial
multiomics. Genetically engineered mouse models (GEMMs) of GBM with defined driver mutations and human
GBM tissues of matching subtypes will be used. We will identify distinct margin-MG populations and pro-
tumorigenic signals originating from margin-MG. We will also conduct co-cultures and ex vivo organotypic brain
slice studies for validation. In Aim 2, we will study the functional significance of margin-MG in promoting GBM
expansion and invasion by examining the efficacy of targeting MG proliferation (via IL-1/IL1R1 signaling), MG
motility/alignment (via Plexin-B2 signaling), or both, using genetic and pharmacological approaches in GEMMs
of GBM. This will provide proof-of-principle that targeting key signaling pathways with different mechanisms of
action may achieve synergistic effects for perturbing the supportive niche provided by MG at invasive margins.
In Aim 3, we will examine the impact of chemoradiation on margin-GBM profiles, gliomagens, and functional
significance in GBM recurrence. The new knowledge will help leveraging the signaling networks underlying
intrinsic functions of tumor-promoting resident innate immune cells in order to curb GBM invasion and relapse.

Public health relevance
NARRATIVE Glioblastoma (GBM) is highly lethal, and a major contributing factor is the infiltrative tumor margin with a tumor- supportive niche for GBM invasion and relapse after therapy. This proposal aims to map the immune contexture, particularly microglia (MG), at GBM margins in order to delineate signaling networks and tumor-promoting factors (gliomagens) derived from margin-MG. Our study will advance basic understanding of tumor-host interactions at GBM margins, and provide proof-of-principle that targeting key signaling pathways with different mechanisms of action in tumor-associated microglia can help slow down GBM invasion and recurrence.